Progression Subtyping and Drug Target Identification for Parkinson's Disease with Integrative Machine Learning

ABSTRACT
Parkinson's Disease (PD) is the second most prevalent neurodegenerative disorder all over the world. It is
estimated that PD affects 2-3% of people older than 65 years. The underlying etiology and pathophysiology of
PD remain unclear to date. Furthermore, PD patients show great heterogeneity in disease progression
throughout the PD course, which is a critical factor that hinders therapeutic development. This creates challenges
in finding effective disease-modifying treatment or prevention strategies. To overcome the challenges, massive
resources for PD study have been built up and become available for research, including clinical, multi-omics,
and neuroimaging data generated from well-designed research initiatives such as the Parkinson's Progression
Markers Initiative (PPMI) and the Parkinson Disease Biomarkers Program (PDBP); general data sources in
biology such as protein-protein interactome network data and functional genomic data; a comprehensive
biomedical knowledge graph (BKG) we built; and continuously increasing volume of real-world patient data
(RWD). Integrative analysis of these massive and heterogeneous data poses considerable challenges to
conventional computational approaches for deriving valuable and reliable insights. Despite the numerous efforts
to develop novel machine learning (ML) algorithms for analyzing these data, they typically focused on one or a
few data types. Therefore, there is a critical need to develop ML methods to perform integrative and effective
analyses of heterogeneous PD data sources to derive comprehensive insights. This project aims to build such a
pipeline with three specific aims. Aim 1 identifies progression subtypes of PD through integrative modeling of
longitudinal clinical, transcriptomic, and neuroimaging data of participants in the PPMI and PDBP cohorts. Aim
2 identifies gene modules that govern the differential PD progression through integrative analysis of multi-omics
data with network medicine and ML. Aim 3 evaluates and validates the gene modules as drug targets through
in-silico drug repurposing with multi-omics, BKG we built, and real-world patient data, respectively. In sum, this
pipeline will perform integrative analysis on the longitudinal clinical data, transcriptomics data, and neuroimaging
data, as well as whole-genome/exome sequencing data from the PPMI and PDBP cohorts, publicly available
human interactome data, functional genomic data, drug-perturbation multi-omics data, our BKG, and the real-
world EHR data from the INSIGHT network (covering ~12 million patients across New York City's Five health
systems and the greater metropolitan area), the Cleveland CIinic EHR database (covering ~11 million patients
extracted from IBM Explorys), and the Temple Health EHR (covering ~1.2 million patients).

Public health relevance
PROJECT NARRATIVE The goal of this project is to build an integrative machine learning pipeline that 1) derives progression subtypes of Parkinson's Disease (PD) from longitudinal clinical assessments, RNA-seq data, and neuroimage acquisitions of individuals diagnosed with PD; 2) identifies subtype-specific gene modules that govern differential PD progression (i.e., progression subtypes) with a diverse set of individual-level genetics and multi-omics data related to PD, functional genomic data, and human protein-protein interactome; 3) evaluates and validates the identified gene modules as drug targets through in-silico drug repurposing using multi-omics, biomedical knowledge graph, and real world patient-level electronic health records (EHR). The developed algorithms and software tools will be made publicly available and widely disseminated in the PD research communities.